STUDY OF INFECTION WITH HUMAN PAPILLOMAVIRUS

This is a MAO for support services for epidemiologic studies to address emergent cancer issues: MAO no. 1 is for the study of human papillomavirus infection and its relationship to cervical displasia and cancer.